Identification of a targeted anti-mitotic agent that degrades Myc and specifically induces cancer cell death

PROJECT SUMMARY
Ovarian cancer is the fifth leading cause of cancer death in women and chemotherapy has remained the
standard of care for decades. Although 70% of high grade serous ovarian cancer (HGSOC) patients initially
respond to platinum-based therapy, nearly all patients succumb due to lack of therapies to treat recurrent,
chemotherapy-resistant disease. Therefore, there is an urgent need to identify targetable vulnerabilities of
HGSOC and to develop new treatments to prolong survival of these patients. To address this problem, our lab
used a computational drug repositioning platform, Drug Predict, to identify amiodarone, an antiarrhythmic agent,
as a potential ovarian cancer treatment. Amiodarone potently decreased cell viability and triggered apoptosis in
numerous patient-derived HGSOC cell lines, including those that were cisplatin-resistant. These effects were
mediated through its ability to degrade c-Myc, which is overexpressed in >45% of HGSOC patients. However,
given the dose-limiting toxicity of amiodarone, we applied structure-activity relationship analysis to identify DL78,
which lacked hERG activity but retained the anti-cancer properties and ability to regulate Myc. DL78 was
significantly more potent and tumor specific than amiodarone, and sensitized cells to platinum therapy. In
addition, DL78 rapidly induced G2/M arrest and mitotic catastrophe, which ultimately led to apoptosis in several
types of cancer cells. Furthermore, though both amiodarone and DL78 affected degradation of Myc, DL78
enhanced Myc phosphorylation on Threonine-58, consequently increasing proteasome-mediated Myc
degradation. Thus, we hypothesize that DL78 induces mitotic catastrophe through Myc degradation and
prolonged spindle assembly checkpoint (SAC) activation. We will test this hypothesis through two aims: 1)
Examine DL78 effects on SAC activity and determine its dependency on Myc. 2) Investigate the compound’s in
vivo efficacy in well-defined patient-derived xenografts. Successful completion of this proposal will improve our
understanding of what molecular processes are vital to ovarian cancer cells’ survival. As a secondary outcome,
it provides a compound that can be further developed into a preclinical candidate for ovarian & other Myc-driven
cancers. The encouraging training environment, plentiful core facilities, and diverse mentorship presented to me
at the University of Michigan will facilitate prosperous completion of these aims and bolster my professional
development as a translational cancer researcher.

Public health relevance
PROJECT NARRATIVE Almost a quarter of ovarian cancer patients experience primary treatment resistance, and a majority of the responding patients fatally relapse. This proposal will address an unmet need by characterizing an antimitotic agent, DL78, which selectively kills ovarian cancer cells and decreases c-Myc, which is overexpressed in >45% of ovarian cancer patients. Successful completion will uncover the mechanism of action and in vivo efficacy of DL78, which will suggest targetable vulnerabilities in ovarian cancer and warrant development of DL78 as a novel therapeutic for Myc-amplified cancers.